Regulating parenchymal repair in wound healing

Project Summary
Many tissues in adult mammals are incapable of regeneration after injury because the parenchymal cells
that provide the specialized tissue functions lack sufficient self-renewal capacity. When parenchymal cells
cannot facilitate tissue regeneration, non-functional fibrotic scarring occurs. In the select tissues that can
regenerate, such as the liver, resident parenchymal cells enter states of high self-renewal upon injury to
enable parenchymal repair and recovery of organ function. Mammalian neonates have parenchymal repair
capacity in most tissues too because newborn immature parenchymal cells maintain elevated levels of self-
renewal, but these cells rapidly become quiescent during postnatal development and lose repair
competency. Based on these insights, an important question remains as to whether parenchymal repair can
be induced in adult tissue injuries simply by enhancing the self-renewal capacity of certain adult parenchymal
cells. Addressing the significant gaps in our understanding of the mechanisms that are responsible for
limiting the injury-induced self-renewal in adult parenchymal cells will be required to answer this question.
Thus, this project is focused on dissecting molecular mechanisms responsible for self-renewal deficiencies in
adult parenchymal cells following injury and testing strategies for improving adult wound healing outcomes by
regulating these processes. We will address fundamental knowledge gaps in parenchymal repair using the
mouse central nervous system (CNS) as a model organ system and focus on one important quiescent
parenchymal cell population in the CNS, astrocytes, for detailed study. As part of this work, we will explore 3
separate but complementary initiatives and use an experimental toolkit of modular biomaterials, in vitro
astrocyte cultures, and mouse spinal cord injury models. In initiative 1, we will dissect the mitotic and anti-
mitotic growth factor signaling that regulates parenchymal repair and we will incorporate injectable
biomaterial coacervates to precisely deliver molecular regulators of this signaling in vivo. In initiative 2, we will
identify metabolic fuels necessary for sustaining parenchymal cell self-renewal after injury and use injectable
glyco-nucleoside copolymer hydrogels to permit prolonged delivery of optimized metabolic fuels to injury
lesions. In initiative 3, we will dissect non-cell autonomous regulation of parenchymal cell self-renewal by
recruited lesion cells by using injectable biomaterials to locally dysregulate these natural injury-induced cell-
cell interactions. Collectively, the three initiatives will shed new light on the molecular requirements for
enhancing parenchymal repair in adult tissue injury and will transform our understanding of wound healing that
will be applicable to many organ systems.

Public health relevance
Ineffective wound repair following tissue injury results in scarring and loss of important organ functions that can have devastating consequences. Here, we focus on addressing fundamental gaps in our understanding of the molecular mechanism involved in poor wound repair outcomes. Successful completion of this project will lead to new strategies for effective regeneration of tissue injuries.